Bioelectrochemistry at the Nanoscale: Fundamentals and Applications

Project Summary
Key questions of the 21st century in medicinal and biochemical areas are focused on the intimate operation
and functionality of biomolecule at the molecular level. By understanding the physical properties of
biomolecules at the nanoscale we can envision how to control them and use them for various applications.
The proposal below is aimed to promote these key questions via the use of nanoscale electrochemistry. I
am very excited to share with you some of our preliminary results and future vision dealing with both the
applied and fundamental sides of Bioelectrochemistry. The first part of the proposal is focused on merges
the lab expertise in nanoelectrochemistry and charge transport phenomena and focuses on an innovative
method to measure the electronic response of individual enzymes during catalysis. By that, we hope to
unravel by electronic means the way that enzymes operate and fluctuate with respect to their catalytic
activity at the molecular level. Gained information can guide us towards the control and design of enzymes
both from fundamental aspects and industrial applications.
The second part of the research program offers a template for a paradigm shift in the way we think about
electrochemical biosensors. We propose to construct a chemically amplified electrochemical system that
enables the detection and analytical sizing of insulating materials, one at a time. We plan to use this
experimental approach for designing a sensor for rapid pathogen detection. The main goal here is to
innovate a sensor that can be used in a personalized fashion, without the need of complex device operation.
Realization of such sensor can potentially mitigate the number of unnecessary antibiotics given at the point
of care.

Public health relevance
Project Narrative Bioelectrochemistry is currently an underused experimental tool that enables to study bioelectrochemical process that cannot be applied by other methods for studying the system's thermodynamic and kinetics. The proposed projects aim to bring new electrochemical techniques to the forefront of studying biological redox reaction. Ultimately, the research proposed is expected to (i) promote a deeper understanding of how single enzymes operate individually, and (iii) develop a new generation of biosensors, potentially stimulating the development of targeted approaches to rapid diagnosis of infectious diseases.